Profiling diarrhea-predominant irritable bowel syndrome (IBS-D) using stool-based RNAs

PROJECT SUMMARY
There are no tests to aid in the diagnosis of irritable bowel syndrome (IBS), which is the most common chronic
gastrointestinal condition in the U.S. and is thought to arise in part from gut host-microbe interactions. Here, we
propose to identify novel stool-based IBS biomarkers by sequencing exfoliated host gut cells and microbiota to
non-invasively assess gene expression and microbiome changes in the gut. Our proposed research comprises
two main aims. Firstly, we will establish a stool-based RNA sequencing method optimized for IBS and combine
it with gut microbiome measurements. Secondly, we will apply our method to patient cohorts to identify stool
RNA and gut microbiome features that could potentially diagnose and subtype IBS-D. This project will focus on
diarrhea-predominant IBS (IBS-D), using test and validation patient cohorts to determine the accuracy of our
method in distinguishing patients with IBS-D from healthy controls. We anticipate that this exploratory work will
deliver a novel method to generate stool-based biomarkers for IBS-D, thereby improving diagnosis, phenotyping,
and subsequent management of the disorder.

Public health relevance
PROJECT NARRATIVE Reliable biomarker assays could greatly improve diagnosis of Irritable Bowel Disorder and its various subtypes. This proposal aims to develop a method to identify nucleic acid biomarkers for IBD directly from stool samples using healthy and IBD associated specimens. Findings from this work will lead to better clinical diagnosis and subtyping of IBD, and more sensitive measurement of response to therapy, all toward the goal of improving patient outcome and reducing clinical cost and resources.